Central IRB Services for DCR/NIAID COVID-19 Clinical Trials

Central Institutional Review Board (IRB) services for the DCR Coronavirus COVID-19 observational study and for the DCR Coronavirus COVID-19 randomized clinical trials